Experience-dependent plasticity of circuit dynamics

PROJECT SUMMARY:
Plasticity of neural circuits is a key element underlying the brain's ability to adapt to experience, and
harnessing plasticity in the brain may provide new therapeutic avenues to ameliorate the effects of early
perturbation or injury. However, our understanding of plasticity in the adult brain remains incomplete. Although
adult plasticity in the visual cortex can be selectively induced through loss of sensory input or repeated
presentation of single stimuli, the impact of more broadly enriched sensory experience is unclear. In addition,
although the role of GABAergic inhibition in developmental visual plasticity has been deeply explored, the role
of inhibitory interneurons in adult plasticity remains largely unknown. In particular, cells that express the peptide
somatostatin (SST-INs) are thought to play a critical role in shaping the feature selectivity of visual responses in
mouse visual cortex, primarily via their robust inhibition of the dendrites of excitatory pyramidal neurons. SST-
INs are also critical mediators of visually-evoked activity patterns that facilitate long-range transmission of visual
information. However, the functional roles of SST-INs in adult plasticity remain unclear. Our preliminary data
suggest the surprising finding that visual experience consisting of repeated presentations of varied stimuli
induces a novel form of plasticity in adult mouse primary visual cortex, leading to robust enhancement of visually
evoked activity in SST-INs. This experience-dependent plasticity is accompanied by altered visual sensitivity in
nearby excitatory neurons. To further explore this observation, we propose to combine a number of
methodological approaches, including 2-photon imaging of identified neural populations, optogenetic
manipulations, and ex vivo synaptic physiology. We will determine the visual experience required to induce this
adult plasticity, identify the underlying cellular and synaptic mechanisms, and examine the functional
consequences for cortical visual encoding and transmission. Our results will provide an unprecedented level of
insight into a novel form of plasticity in the adult cortex and identify underlying cellular- and circuit-level
mechanisms.

Public health relevance
PROJECT NARRATIVE: Induction of plasticity is a potential therapeutic avenue for ameliorating neural deficits due to early perturbation, such as amblyopia, but the mechanisms underlying plasticity in the adult brain are not fully understood. This proposal will examine a novel form of adult plasticity in the visual cortex and identify how interneurons that express somatostatin (SST-INs) contribute to experience-dependent plasticity in mouse visual cortex. We expect our findings to provide important insights into the cellular underpinnings of plasticity in the adult brain.